Enteric nervous system-macrophage interactions in Hirschsprung-associated enterocolitis

Abstract/Project Summary: The gut is richly innervated by a dense network of intrinsic neurons and glia
called the enteric nervous system (ENS). The ENS controls most aspects of bowel function including motility,
blood flow, epithelial function, and immune cell activities. In 1:5000 children the ENS is missing from the distal
bowel, a birth defect called Hirschsprung disease (HSCR). Children with HSCR are prone to HSCR associated
enterocolitis (HAEC), a life-threatening colon inflammation. Although there are treatments for HAEC, many
children have ongoing symptoms and the mechanisms underlying the enterocolitis remains poorly understood.
In particular, how the absence of the ENS affects local immune cells and mechanisms of ENS-immune cell
interactions are largely unexplored. Preliminary results in our murine HSCR model reveal increased
macrophage infiltration of the distal colon that lacks ENS and changes in macrophage morphology that
suggest altered macrophage function and roles for macrophage in colitis of the HSCR bowel. To find new ways
to prevent HAEC, we will test the hypothesis that bowel macrophage phenotype changes in response to
vasoactive intestinal peptide (VIP) or the absence of VIP signaling. VIP is an abundant ENS neurotransmitter
that induces anti-inflammatory effects in diverse immune cell subtypes. We also will determine if reducing
macrophage abundance or skewing macrophage toward an anti-inflammatory phenotype will reduce colitis
severity in a HSCR model. These studies will provide new insight into neuro-immune interactions in the context
of a HSCR disease model, and these results may suggest new strategies to treat or prevent HAEC.

Public health relevance
Project Narrative: Hirschsprung disease associated enterocolitis (HAEC), a life-threatening inflammation caused by the absence of enteric nervous system (ENS) cells in distal colon, has few effective treatment strategies in part because underlying cellular and molecular mechanisms that cause HAEC remain incompletely understood. Our goal is to define neuro-immune interactions that impact the likelihood of colon inflammation when the ENS is missing. By defining disease mechanisms, we hope to find new HAEC treatment and prevention strategies.